Dissecting the role of ventral pallidal circuitry in cocaine seeking after the withdrawal

PROJECT SUMMARY
Drug craving during prolonged periods of abstinence is a major factor driving repeated cycles of
drug abuse. In light of the increasing prevalence of drug abuse, it is imperative that we obtain a
clear understanding of the neural circuit plasticity and associated molecular mechanisms
underlying drug craving specifically. The ventral pallidum (VP) is the major output structure of the
mesolimbic reward circuitry and is suggested to be the final common pathway for reward and
motivational processing by relaying information from the nucleus accumbens (NAc) and ventral
tegmental area (VTA) to the lateral habenula (LHb), VTA, and subthalamic structures. However,
little is known about the circuit level organization and function of VP neurons in drug addiction,
especially in the context of drug seeking following prolonged withdrawal. Therefore, we will
anatomically and functionally probe the neural adaptations of a molecularly-defined subset of VP
output neurons using the cocaine self-administration paradigm in mice, in order to better
understand the mechanisms underlying cocaine seeking after a prolonged period of withdrawal.
To accomplish this, we propose to study withdrawal-induced neural adaptations in specific
subcircuits originating in the VP by using multiple cutting-edge techniques including optogenetic
manipulation, in vivo monitoring of neural activity, viral-mediated tracing, ex vivo electrophysiology,
and molecular profiling methods in a mouse cocaine self-administration model of drug addiction.
Our preliminary data indicate that dopamine receptor 3 (Drd3) signaling is selectively upregulated
in the VP during withdrawal from cocaine self-administration, and that knockdown of Drd3 in the
VP, but not in the NAc, inhibits cocaine seeking behavior after prolonged withdrawal, but not
sucrose reward seeking, strongly suggesting that VP Drd3 signaling may play a major role
specifically in cocaine-induced craving and drug seeking behavior. We will first define the afferent
and efferent connections of Drd3-expressing VP neurons. Second, we will examine the circuit-
specific neural adaptations of VP Drd3 neurons and their role in cocaine seeking. Third, we will
examine how VP Drd3 neuronal activity regulates VTA dopaminergic neuronal activity and
dopamine release in NAc and VP during prolonged withdrawal from cocaine self-administration
using cutting-edge imaging techniques. The accomplishment of this project will be greatly
beneficial in providing a framework for studying drug addiction in a circuit-specific manner, as well
as in developing a strategy for the treatment of drug addiction.

Public health relevance
PROJECT NARRATIVE A persistent issues in the treatment of cocaine addiction is the reinstatement of cocaine seeking even after the long period of withdrawal. The goal of this proposal is to take advantage of recent technological advances to dissect and identify specific neural circuitry and neural adaptions as well as molecular mechanisms that underlie the reinstatement of cocaine seeking after the withdrawal, with the ultimate goal of contributing to the treatment of the drug addiction.